Identification and Validation of Epigenetic Biomarkers of PMDD

PROJECT SUMMARY
Premenstrual dysphoric disorder (PMDD) is a reproductive affective disorder with impairing mood symptoms
that emerge monthly in the premenstrual (luteal) phase of the menstrual cycle. Excitingly, in recent exploratory
analyses by our team, epigenetic biomarkers of postpartum depression also distinguished PMDD cases from
controls in the luteal phase of the menstrual cycle. Reproductive affective disorders, including PMDD and
postpartum depression, can be conceptualized as disorders of hormone sensitivity - an abnormal brain
response to ovarian hormone fluctuations. Epigenetic variations at the TTC9B and HP1BP3 loci identified by
Co-Is Payne and Kaminsky were prospectively predictive of postpartum depression risk across multiple studies,
with over 80% accuracy. Recently, in a cross-sectional cohort of 50 women with and without PMDD, this
postpartum depression epigenetic biomarker linear model distinguished PMDD cases from controls in the
luteal phase, suggesting our biomarkers may be markers of sensitivity to reproductive hormone change. The
primary aim of this R01 is to explore whether the epigenetic biomarkers may represent a broad marker for
hormone sensitivity, by assessing women (controls, PMDD) in both the follicular and luteal phases of their
menstrual cycles, using a repeated measures approach instead of cross-sectional. A secondary aim is to
examine whether our epigenetic biomarkers differ between women with PMDD who have responded to
selective serotonin reuptake inhibitor (SSRI) treatment versus those who have failed SSRIs. SSRIs are the
first-line treatment for PMDD, yet 40-50% of PMDD patients do not respond to SSRIs. Preliminary data from PI
Hantsoo’s laboratory suggests that this epigenetic biomarker may distinguish between SSRI responders and
nonresponders in PMDD. Importantly, SSRI treatment response prediction was validated in a prospective
postpartum depression cohort, differentiating SSRI responders from non-responders with an AUC of 0.86 (95%
CI: 0.63-1). These data suggest that these epigenetic biomarkers may represent a biology important for SSRI
response in reproductive affective disorders, which are understudied and have limited effective treatment
options. The proposed study will apply our published postpartum depression biomarker linear model to DNA
methylation generated by targeted pyrosequencing at TTC9B and HP1BP3 in a cohort of women with PMDD
and controls. We will compare the epigenetic biomarker between controls and PMDD in the follicular and luteal
phases. Within the PMDD group, we will compare the biomarker between those who have responded to SSRI
treatment and those who have not. Blood will be collected at home by participants using a dried blood spot
collection system. DNA will be extracted from blood spots and subjected to sodium bisulfite modification and
hybridized to a CLIA certified Illumina MethyEPIC Beadchip. Methylation patterns analyzed by Co-I Kaminsky
who will use the published algorithm for postpartum depression to determine if the biomarkers predict PMDD.

Public health relevance
PROJECT NARRATIVE Premenstrual dysphoric disorder (PMDD) is a reproductive affective disorder with impairing mood symptoms that emerge monthly in the premenstrual (luteal) phase of the menstrual cycle, is conceptualized as a disorder of hormone sensitivity, and is challenging to diagnose, often mistaken for other disorders. We previously identified epigenetic biomarkers of postpartum depression, another reproductive affective disorder, and in this study aim to determine if these biomarkers also distinguish PMDD cases from healthy controls at different points in the menstrual cycle. This research would reveal whether this epigenetic biomarker represents a general biomarker for hormone sensitivity and vulnerability to reproductive affective disorders which are understudied and have limited treatment options, and, were a reliable biomarker found, could facilitate diagnosis of this underrecognized and often misdiagnosed disorder.